Pathogenic role of IL-39/IL-39R signaling in graft-versus-host disease

Abstract
Graft-versus-host disease (GVHD) remains a significant source of transplant-related mortality and morbidity
after allogeneic hematopoietic cell transplantation (allo-HCT). Inflammatory cytokines play an essential role in
T-cell activation and differentiation to pathogenic cells, and thus promote development and progress of GVHD.
Among cytokines, IL-12 family especially IL-12 and IL-23 has been shown to substantially contribute to the
pathogenesis of GVHD, at least partially through promoting Th1 differentiation and Th17 maintenance,
respectively. Recently, IL-39 has been proposed as a new addition to IL-12 cytokine family that consists of p19
and EBV-induced gene 3 (Ebi3). While several groups provided compelling evidence to support the presence
and activity of IL-39 in preclinical murine models as well as in clinic, others failed to validate this newly
proposed cytokine especially in human cells. Our preliminary study provides evidence that IL-39 exists and
correlates with GVHD development not only in preclinical murine models but also in patients after allogeneic
HCT. However, the functional relevance of IL-39 has not been established. The goal of this proposal is to
evaluate the pathophysiologic relevance of IL-39 in GVHD development in mice and humans. Our central
hypothesis is that IL-39/IL-39R signaling promotes T-cell activation and effector function, and thus promotes
GVHD pathogenesis. This hypothesis will be tested by pursuing two Specific Aims: 1) To validate the role of
IL-39/IL-39R signaling in GVHD and GVL activity in preclinical models; 2) To determine the functional
relevance of IL-39 in humans. The research proposed in this application is considered highly innovative,
because, as a newly proposed cytokine, validation of IL-39 existence and activity is urgently needed in general,
and the current study is expected to be the first investigation of IL-39 in GVHD pathogenesis. The proposed
research is significant biologically and clinically, because it is expected to verify the existence and biological
function of IL-39 in mouse and man, and to validate IL-39 or its receptor as a potential biomarker for diagnosis
or prognosis of GVHD as well as a therapeutic target in GVHD and beyond.

Public health relevance
Narrative Allogeneic hematopoietic cell transplantation (allo-HCT) is a curative option for patients suffering from benign or malignant hematological diseases, but a major complication of allo-HCT procedure is graft-versus-host disease (GVHD) as it remains a prominent cause of transplant-related morbidity and mortality. Inflammatory cytokines play an essential role in promoting the development and progress of GVHD. The current research is designed to validate the existence and activity of interleukin-39 (a newly proposed cytokine) in GVHD, and to evaluate it as a potential biomarker for diagnosis or prognosis of GVHD as well as a therapeutic target for controlling GVHD and other immune related disorders.